High-throughput optical investigation into intact large-scale nervous systems for Alzheimer's disease

Project Summary
Alzheimer's disease (AD) is an irreversible neurodegenerative disease with its underlying cause poorly
understood. Current discoveries on its pathological origin have mainly stemmed from studies on
microscopic systems with limited number of cells. While increasingly many evidences have indicated
that the interaction among various groups of cells across the entire nervous system holds the key to
those unanswered questions in AD, large-scale volumetric investigation are limited by current imaging
technologies. First, microscale methods used in conventional histopathology, such as electron or light
microscopy, require extensive tissue sectioning for thick samples, leading to prolonged imaging time
and the difficulty of 3D reconstruction from 2D images due to tissue deformation. On the other end,
insufficient spatial resolution and limited molecular specificity of macroscale approaches, such as
MR/PET/CT, have made them less attractive for pathological studies. Thus, the goal of this project is
to develop an optical imaging method that not only provides high resolution and molecular contrast
suitable for the pathology of the nervous systems in AD mouse models, but also offers enabling high-
throughput for those large-scale investigations demanded by many of today's AD research. This
proposal plans to address the above imaging needs by creating coherent imaging apparatus, such as
interferometry and holography, to provide the enabling high-throughput and high resolution, by
developing new tissue processing methods to offer the molecular contrast, by building computational
tools to assist the biological interpretation of imaging results. The proposed research is expected to
generate a set of new research tools that enable large-cohort studies with brain-wide big-data
acquisition and analysis. The Pl (Dr. Jian Ren) will obtain complementary expertise from his mentors,
a team of leading scientists including Dr. Brett Bouma (optical imaging), Dr. Bradley Hyman
(neurology and AD), Dr. Sangeeta Bhatia (nanomedicine and tissue engineering), Dr. Tayyaba Hasan
(photodynamic therapy), Dr. Edward Boyden (neuroscience and optogenetics), and Dr. Bruce Fischl
(computational neuroimaging and MRI). Leveraging the support from the Pl's mentors, he will have
access to numerous research facilities at the greater community of Harvard and MIT. Enjoying this
highly multidisciplinary and collaborative research environment, Dr. Jian Ren will undertake this
mentored research and transition to his research independence.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is an incurable neurodegenerative disease that progressively destroys patients’ cognitive functions causing enormous social and economical impact. With its underlying cause poorly understood, new imaging technologies are in demand to provide more comprehensive etiological investigation of AD over large-scale complex nervous systems, such as whole brains. In this proposal, to address this unmet need, we are to develop advanced optical imaging tools that can enable 3D brain-wide visualization of AD pathology.